Biological roles of ADAMTS Proteases

Abstract ADAMTS metalloproteases are prominent in arthritis as aggrecan-degrading enzymes (aggrecanases), with ADAMTS5 being a major target for drug development. ADAMTS9 and ADAMTS20 are the most highly conserved members of this protease family, and are evolutionarily related to Gon-1, a worm metalloprotease essential for gonadal morphogenesis. We identified new singular and cooperative functions of Adamts5, Adamts9 and Adamts20 in the previous funding period. Adamts9 null mice die without gastrulating and Adamts20 mutant mice (belted, bt) have defective melanoblast colonization of skin. bt/bt;Adamts9+/- mice die at birth with a complete cleft of the secondary palate, and show greater impairment of pigmentation than bt mice, indicating cooperative roles of ADAMTS9 and ADAMTS20. bt/bt; Adamts5-/- mice and Adamts9+/-;Adamts5-/- mice develop soft-tissue syndactly (STS), owing to failure of apoptosis during interdigital web regression. STS in these combinatorial mutants is present at a higher frequency than in Adamts5, Adamts9, or bt mice alone. All three proteases process the proteoglycan versican. Versican cleavage is reduced in bt skin and bt/bt;Adamts5- /- webs during their regression, and Vcan interacts genetically with these proteases in STS and cleft palate. Moreover, biochemical studies and genetics identified fibulin-1 as a co-factor for ADAMTS5 in web regression. Rescue of STS by exogenous BMP4 suggests impairment of BMP signaling in the absence of the ADAMTS proteases. Hypothesis: ADAMTS5, ADAMTS9 and ADAMTS20 cooperate within specific molecular networks, which contain fibulins and versican, to influence signaling in craniofacial and limb development. Specific aims: 1: To determine the role of Adamts9 in craniofacial and limb development. 2. To define molecular mechanisms of syndactyly in Adamts deficient mice. 3: To uncover the operational mechanisms of ADAMTS proteases by characterizing versican processing and fibulin interactions. Significance: Understanding the fundamental biology of limb and craniofacial development is key to several common congenital malformations, such as cleft palate. ADAMTS5 is a major therapeutic target in arthritis;understanding its normal function and mechanisms, as well as of closely related proteases, is thus essential for insights on potential side effects and off-target effects of inhibitors, and for development of new therapeutic approaches.

Public health relevance
Proteases are implicated in many human disorders. Cleft palate, the most frequent human birth defect, and developmental limb anomalies, both of which we demonstrate in ADAMTS deficient mice, have significant functional, psychological, socio-economic and medical implications. We have identified the first physiological role of ADAMTS5, the key aggrecan-degrading enzyme responsible for the loss of cartilage in arthritis, and now a major drug target in this chronic disorder. The studies are potentially important for determining the role of ADAMTS proteases in major biological processes, providing fundamental insights on limb and craniofacial development, determining the underlying biochemical pathways, and revealing how they may be perturbed by ADAMTS inhibitors.